Effects of Racism on Brain and Physiological Pathways to Health Disparities

Project Summary
Racism is one of the most urgent and broadly impactful crises in contemporary society, increasing an
array of adverse health outcomes including mortality in Black Americans, yet neuroscientists and
psychologists have heretofore shied away from directly examining personal experiences with racism
and their consequences on the brain, mind, and body. Such investigation is essential because it will
allow us to better characterize mechanistic pathways linking experiences with racism to health
disparities and to devise potential strategies for addressing such disparities. Repeated exposures to
racism likely trigger and amplify a cascade of stress-related brain and physiological responses that are
known to mediate elevated risk for adverse health outcomes. In this project, we will examine several
elements of this mechanistic cascade. We aim to apply validated scientific paradigms in novel ways to
examine brain, physiological, and psychological responses to the recollection of specific personal
experiences with racism – compared to other types of life experiences – among people who identify as
Black or African American. We will also use prospective smartphone-based ecological momentary
assessment (EMA) methods to measure the frequency and severity of experiences with racism as they
occur in daily life in real time, and we will associate these measures with brain, physiological, and
health outcomes. We will examine the relationship between brain/physiological responses to racism
and health outcomes and functioning measures – such as psychological distress, cardiovascular
disease risk, cellular aging (telomere length), hair cortisol, coping, emotion regulation, and social
support – and determine whether brain and physiological responses mediate the relationship between
extent of racism exposure and health outcomes. The proposed investigation represents an innovative
paradigm shift, in which racism is treated like other pathophysiological processes that affect health. We
have assembled an interdisciplinary team with expertise in areas including neuroimaging, trauma,
biomarkers of stress, physiological perspectives on health disparities, ecological momentary
assessment, emotion regulation, and the empirical study of anti-Black racism, yielding a collaborative
effort that is unique and synergistic. It is an approach with potential to transform the way that
neuroscientists and psychologists conceptualize and study racism, helping to overcome some of the
obstacles that have prevented previous scientific investigation of personal experiences with racism.
Among our central aims is to increase the representation of a minoritized participant population that has
been historically undersampled in NIH-funded research, and to promote the training and career
advancement of underrepresented research trainees, consistent with NIH goals.

Public health relevance
Project Narrative Racism is a continued threat to public health and a major factor in the morbidity and reduced life expectancy of Black Americans and hence is one of the most urgent and broadly impactful crises of contemporary society, yet the mechanistic pathways linking personal racism experiences with adverse health outcomes have not been examined using rigorous neuroscience techniques within an interdisciplinary framework. The proposed research will be conducted by an interdisciplinary team including trainees from underrepresented groups, will examine the effects of personal experiences with racism on the brain, mind, and body, and will determine how these changes associate with adverse health outcomes.